Assessing the role of liver stage antigens-specific antibodies against Plasmodium falciparum liver stage infection

PROJECT SUMMARY
The recent discovery of Plasmodium falciparum (Pf) liver stage antigens (LS Ags) is providing us
with an opportunity for conducting explorations of the utility of these Ags as vehicles to prevent
malaria and also as tools for seeking a better understanding of the Plasmodium LS development.
Amongst the Plasmodium spp., Pf remains one of the deadliest infectious diseases that plagues
many parts of the world and anti-malaria approaches are not fully effective. Currently, these
approaches have been shifting towards the development of human monoclonal antibodies
(hmAbs) as a more effective anti-malaria measure. Clinical trials are underway with hmAbs
directed to a single target, the circumsporozoite protein (CSP). It is likely that similar to CSP-
based RTS,S vaccine, mAbs directed to a single Ag, the CSP, may be insufficient to prevent
malaria. Even a single spz that escapes anti-CSP Abs will infect hepatocytes and initiate clinical
malaria. We are proposing an alternative strategy that may improve the CSP-based preventative
measures. We would incorporate Ags expressed during the Plasmodium LS development. We
hypothesize that a combination of Ags that includes CSP and LS Ags would provide a broader
Ab specificities and a wider coverage against the parasite. We have previously demonstrated in
a mouse model that P. berghei and P. yoelii LS Ags, orthologues of Pf LS Ags, reduce liver
parasite burden (LPB) following spz challenge. When co-administered with Pb CSP, some Pb LS
Ags induced sterile protection in 80% as compared with ~40% protection of mice that received
only Pb CSP or a combination of the 3 Pb LS Ags. Like CSP, the Pb LS Ags induced antibody
responses to Ags on spz and infected hepatocytes. On the basis of these results we hypothesize
that a cocktail of mAbs specific for targets on CSP and LS Ags is needed for an efficacious
approach to prevent malaria. The availability of the humanized DRAGA mouse - with its
developed functional human immune system, human hepatocytes, Kupffer cells, and
erythrocytes, which allow complete vertebrate Pf life cycle - presents an ideal model for (1)
producing Pf LS Ags-specific hmAbs and (2) subsequently for testing the efficacy of a cocktail of
Pf CSP- and LS Ag-specific hmAbs in preventing malaria infection after Pf spz challenge. The
successful production Pf LS Ags-specific hmAbs could be used to enhance protection mediated
by CSP; these hmAbs also would provide reagents needed towards explorations of the
mechanism of liver pathogenicity as well as organ-specific immunogenicity of Plasmodium LS
Ags.

Public health relevance
PROJECT NARRATIVE The availability of novel Plasmodium falciparum (Pf) liver stage antigens (LS Ags) as proteins will be used an excellent tool for the explorations of methods to develop new biological reagents, like monoclonal antibodies, to prevent malaria infection. Humanized DRAGA mice contain fully developed human immune system, human hepatocytes, and liver macrophages, and they are an excellent model to the production of monoclonal antibodies to Pf LS Ags. These mice are able to support the full development of P. falciparum and therefore will also be used to test for the efficacy of monoclonal antibodies against infection with Pf sporozoites.